Understanding the Interplay between Parent and Child Contributions in Parent-Child Anxiety Transmission

Project Abstract
This document has not changed from the original submission and is not required by PA-23-189.

Public health relevance
Project Narrative This document has not changed from the original submission and is not required by PA-23-189.